High-content study to analyze the nutritional value of natural products for healthy aging

As lifespans increase and the population of older adults grows, there is a mounting need for ways to stay healthy
during aging. Neuromuscular health is an important aspect as it allows people to participate in regular daily
activities and lowers the risk of fall injuries. Currently, there is a lack of safe and effective drugs to treat muscle
health decline (sarcopenia), which has a complex set of mechanisms and etiology. However, consuming natural
products can benefit muscle health and promote healthy aging. While the natural product market is growing
globally, there is still a lack of unified knowledge about their safety and efficacy, partly due to a lack of cost-
effective and rapid screening capabilities. Standard testing methods, such as rodent models are time-consuming,
expensive, and increasingly restricted by legislation due to ethical issues. New Approach Methodologies (NAMs)
such as in silico analysis, microphysiological systems, and alternative model organisms such as zebrafish and
C. elegans are gradually replacing these methods. Among these model organisms, C. elegans is particularly
well suited to study aging due to its short life cycle (~5 days from hatching), simple and inexpensive culture, high
genetic homology (~70%), and conserved muscle structure and physiology with humans, targeted CRISPR
modifications, and amenability to microfluidics and high throughput screens. Current methods for studying C.
elegans during aging have limited scalability and higher costs as they can only support a few populations and
animals or require constant imaging and feeding on expensive microfluidic imaging systems.
We have developed the first high-throughput scalable phenotypic screening platform for conducting
efficacy and toxicology studies with C. elegans using our patented vivoChip platform. This automated imaging
platform can collect multi-color, high-resolution, timelapse images of ~1,000 animals over 24 individually treated
populations in ~30 min. This proposal aims to develop assays to assess the effects of natural products, including
whole plant extracts and their individual compounds on slowing the decline in muscle health in aging worms. In
Aim 1, we will develop imaging-based assays to characterize muscle mass, mitochondria volume, and protein
homeostasis in aging worms using reporter strains We will also develop fully automated image-analysis pipelines
for these health assessments to allow high-throughput screens. In Aim 2, we will assess the developmental
toxicity of 10 natural products using N2 strains using our established developmental toxicity assays using body
volume as an endpoint and look at cellular stress using autofluorescence. Once our new assays are established
and we have found the toxicity points of departure for the 10 products, we will study their health benefits with the
new assays using the vivoChip-24x device. The outcome of this work will be a dataset describing the relative
health benefits of these products over any potential toxicity. The robust protocol and analysis pipeline will allow
us to test a large set of natural products and lay down the foundations for our customers to use C. elegans-
based NAMs for in vivo testing to bring safe and effective products to market and minimize health risks.

Public health relevance
Project narrative: Natural products such as herbal supplements and food ingredients are widely used to support muscle health during ageing, but the efficacy and toxicity of these products are not fully understood. Most information currently comes from existing clinical data limited to only similar products or from studies in mammals, which take a long time and are expensive and ethically problematic. The proposed project will develop a rapid, inexpensive, and ethical method of testing the effects of natural products to support muscle health effectively and safely by using a tiny soil-dwelling nematode as a model to predict effects in humans.